EFFECTS OF THE TOPICAL ANESTHETIC LIDOCAINE IN THE RECTUM

The purpose of this study is to test the effects of the topical anaesthetic Lidocaine on reflexes and sensations in the rectum. The effect of Lidocaine-induced analgesia on bisacodyl will be determined. Subjects having Irritable Bowel Syndrome are studied.